Meet me where I am: A multilevel strategy to increase PrEP uptake and persistence among young sexual and gender minority men in rural NC

PROJECT SUMMARY
Improved linkage to and uptake of pre-exposure prophylaxis (PrEP) is critical to end the HIV epidemic in the
United States (US). Despite PrEP’s high efficacy, less than 20% of PrEP-eligible people have received a
prescription and gaps in uptake expose regional and racial disparities. In 2018, the US South accounted for
more than half of all new HIV diagnoses but only one-third of PrEP users. PrEP use in North Carolina (NC)
similarly lags, with uptake lowest among young sexual and gender minority populations (YSGM) who account
for nearly two-thirds of the state’s incident infections. Among NC counties with the highest rate of HIV
diagnoses, four have rural designation and nine are small or medium metropolitan areas. NC’s HIV epidemic
thrives alongside rising sexually transmitted infections (STI), which are also frequently concentrated in rural
areas. Despite behavioral risk overlap of incident STIs and HIV, in NC, PrEP is only offered at a few, primarily
urban health department (HD) affiliated STI clinics. The lack of robust healthcare infrastructure in rural areas,
and persistent intersecting stigmas for YSGM of color, present unique challenges for HIV and STI prevention.
Leveraging HD-affiliated STI clinics as an on-ramp to PrEP is an ideal opportunity to capitalize on STI service
encounters and address disparities in YSGM’s PrEP access. A pathway to PrEP that utilizes existing clinic
infrastructure to identify potential PrEP users, adapts services to ameliorate clinic constraints, and tailors PrEP
engagement tools to specific client needs is a compelling strategy to improve PrEP access, uptake, and
persistence in rural NC. This multilevel intervention to link PrEP and STI services, addresses barriers at policy,
clinic, provider, and user levels. The strategy builds capacity and confidence via clinic training; facilitates
patient handoff to navigators for linkage to financial support; and uses an evidence-based digital health
platform, connecting users to peer educators, PrEP resources, and telehealth providers. The overarching
objective is to parlay YSGM’s episodic STI service encounters into linkage to convenient, continuous PrEP
care in NC. This objective will be accomplished in four aims. In Aim 1, investigators conduct a randomized trial
at eight rural and peri-urban HD-affiliated STI clinics, enrolling YSGM into the above-described intervention or
control based on enrolling clinic group assignment. The primary outcome is PrEP uptake within 3 months of
clinic visit. In Aim 2, investigators conduct a cost-effectiveness analysis, including a budget impact analysis,
examining cost per new PrEP initiation. If pre-defined go/no-go criteria are met, Aim 3 will proceed by engaging
key stakeholders to refine the intervention, using an Intervention Mapping framework and informed by
effectiveness outcomes and cost levers. Finally, in Aim 4, the refined intervention will be expanded to all eight
clinics to examine impact on PrEP uptake and finalize cost estimates. If successful at increasing PrEP use and
cost effective for increasing PrEP uptake and averting HIV infections, this intervention can be adapted for other
populations and scaled up to STI clinics across NC and other rural and peri-urban areas in the US.

Public health relevance
PROJECT NARRATIVE HIV pre-exposure prophylaxis (PrEP) is a cornerstone to ending HIV in the United States (US), but gaps in PrEP uptake expose regional and racial disparities; despite accounting for the majority of new HIV infections, PrEP use remains exceedingly low among young sexual and gender minorities (YSGM) in the US South. In North Carolina, the HIV epidemic is uniquely concentrated in more rural counties, presenting unique HIV prevention challenges including provider shortages, over-burdened health departments, intersectional stigmas, and lack of PrEP knowledge among providers and rural YSGM. In this project, we will partner with state and local health department sexually transmitted infection clinics to examine a multilevel intervention targeting PrEP use barriers at the policy, clinic, provider, and PrEP user levels, with the goal of increasing PrEP uptake and persistence among YSGM via an integrated, cost-effective, and scalable strategy.